Project 3: A Multilevel HPV Self-Testing Intervention to Increase Cervical Cancer Screening among Women in Appalachia

PROJECT SUMMARY – PROJECT 3
Most cases of cervical cancer occur among unscreened and under screened women. Strategies to increase
screening among these women, including HPV self-testing, have therefore been identified as the most
important cervical cancer screening research priority. HPV self-testing involves women using a device to
collect their own cervicovaginal sample for HPV testing. International studies have repeatedly shown that many
unscreened and under screened women will use an HPV self-test at home and return it by mail, and recent
efforts in the United States (US), including our own work, have established the feasibility of implementing such
mail-based programs. An important next step in this field of research is to examine the effectiveness and
implementation of a large, mail-based HPV self-testing program in the US.
The overall goal of the proposed project is to determine the effectiveness and implementation of a multi-level
cervical cancer screening intervention that features HPV self-testing for unscreened and under screened
women from Appalachia, a region with longstanding cervical cancer disparities. The intervention will include
mail-based HPV self-testing (patient-level), healthcare provider education sessions about HPV self-testing
(provider-level), and patient navigation for women who do not initially return their HPV self-test or who
subsequently test positive for a high-risk (i.e., oncogenic) HPV infection (system-level). The proposed study will
include 1180 unscreened and under screened Appalachian women who are ages 30-64 and be implemented
as part of the integrated health system-based cervical cancer prevention program “Improving Uptake of
Cervical Cancer Prevention Services in Appalachia.”
Importantly, the proposed project will take an effectiveness-implementation hybrid approach that will allow for
the assessment of both intervention effectiveness and implementation. Specific aims will address each
outcome type (service, implementation, and client outcomes) recommended for implementation research: Aim
1 (service outcomes) will determine the effectiveness of the multi-level intervention in increasing cervical
cancer screening (primary outcome); Aim 2 (implementation outcomes) will assess the acceptability, fidelity,
sustainability, and cost-effectiveness of the intervention; and Aim 3 (client outcomes) will determine satisfaction
with the intervention at the patient-, provider-, and system-level. Each aim will make a significant research
contribution and, taken together, will be one of the most innovative and comprehensive HPV self-testing efforts
to date in the US. As HPV self-testing continues to emerge as a cervical cancer screening strategy in the US,
these findings will provide an evidence base on both intervention effectiveness and implementation that will be
highly valuable in guiding future HPV self-testing programs and cervical cancer screening policies.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 This project will evaluate a multilevel cervical cancer screening intervention centered around HPV self-testing. This project is responsive to the mission statement of NCI by improving women's health and advancing scientific knowledge on HPV self-testing as a cervical cancer screening strategy. This project is relevant to public health by directly addressing: a) Healthy People 2020 objectives to reduce cervical cancer rates and increase cervical cancer screening; and b) a high-priority research area identified by several national health organizations.